ATF3 Regulation of Histone Acetylation in Genome Maintenance

Project Summary
A better understanding of the DNA damage response (DDR) is of utmost importance because this
evolutionally-conserved genome-maintaining mechanism not only serves as an anti-cancer barrier, but
influences efficacies of radiation therapy and chemotherapy that mainly kill cancer cells by inducing DNA
damage. Whereas DNA is embedded in highly-ordered chromatin, DNA damage promptly induces chromatin
alterations at sites of damage. One such early change, histone acetylation catalyzed by histone
acetyltransferases Tip60 and p300/CBP, not only can promote chromatin access to the DNA-repair machinery,
but can regulate DNA-repair pathway choice. As histone acetylation has emerged as a principal mechanism for
coordinating DDR, it is of significance to identify genes that can regulate this event upon DNA damage.
Activating transcription factor 3 (ATF3) is a stress sensor commonly induced by DNA-damaging agents. We
have demonstrated that ATF3 can activate the tumor suppressor p53 while promoting Tip60-mediated
activation of the major DDR kinase ATM. We also found that ATF3 is required for genome maintenance and
the suppression of spontaneous tumorigenesis in mice. Whereas these results support that ATF3 plays an
indispensable role in the DNA damage response, what is currently unknown is whether ATF3 can also actively
regulate chromatin dynamics and DNA repair independent of its regulation on p53 and Tip60. The objective of
this application is to address this question, and to determine the role of ATF3 in the regulation of DNA repair at
the chromatin level. Formulated on the basis of compelling preliminary data, the central hypothesis is that
ATF3 recruited to sites of DNA damage promotes p300/CBP to acetylate H3 facilitating the loading of repair
proteins for non-homologous end-joining (NHEJ). To test this hypothesis, we will determine how ATF3 is
recruited to DSBs and promotes p300/CBP-catalyzed histone acetylation at DSBs (Aim 1). We will also
delineate how histone acetylation regulated by ATF3 alters chromatin structure and facilitates the recruitments
of NHEJ factors (Aim 2). Lastly, we will also use the IR-induced lymphomagenesis mouse model to assess the
functional significance of our novel findings (Aim 3). Completion of the proposed research is expected to define
a novel role that ATF3 plays in genome maintenance, and discover novel mechanisms by which the early
chromatin response to DNA damage is regulated.

Public health relevance
Project Narrative The goal of this project is to characterize an emerging tumor suppressor ATF3 for its roles in regulating cells’ ability to repair DNA damage. Successful completion of the proposed research will culminate in a better understanding of how cells defend themselves from DNA damage and malignant transformation, and ultimately lead to the development of novel anti-cancer therapies. This study will also have a potential to identify biomarkers for predicting patient responses to radiation therapy and thus lead to improved treatment outcomes that would benefit millions of people suffering from cancer.